Tumor-directed immunostimulatory nanoparticles for novel 'prime-pull'cancer vaccination

PROJECT SUMMARY
Despite their transformative promise, traditional cancer vaccines have had poor clinical responses since
vaccine-specific systemic T cells often cannot traffic to immunosuppressed “cold” tumors. Traditional vaccines
generate only a lymph node-derived augmentation or “prime” of systemic CD8+ T cells that are trained to
comprehensively seek and eliminate specific target tumor cells. Traditional strategies, however, have been
short-sighted in that they have failed to develop methods to recruit these T cells to the “cold” tumor
microenvironment (TME) that advances by building a formidable local immunosuppressive barrier driven
largely by dysfunctional innate immune cells. Our strategy seeks to reprogram dysfunctional tumor-resident
innate antigen-presenting cells (APCs), such as dendritic cells (DCs) and macrophages, by driving a local anti-
tumor immune response with a proinflammatory cytokine gradient that reshapes the TME from non-inflamed
and “cold” to inflamed and “hot” to recruit or “pull” systemic T cells in from a “prime”. In our recent Cancer
Research paper (Atukorale et al. 2019) and additional preliminary data, we report on the development of a
“pull” strategy based on a novel immunostimulatory nanoparticle (immuno-NP) that is significant due to key
engineering design features. Immuno-NPs co-encapsulate two synergistic immune agonists on the same
particle, cdGMP, an agonist of the STING pathway, and MPLA, an agonist of the TLR4 pathway, to promote a
robust production of proinflammatory Type I interferon ß in target APCs. Immuno-NPs can be safely delivered
in the systemic blood circulation to achieve widespread and preferential deposition in the tumor perivascular
regions that are rich in their target APCs. Immuno-NPs drive a powerful local self-amplifying anti-tumor
immune response that harnesses otherwise “exhausted” immunosuppressed local CD8+ T cells as the key
effectors of tumor clearance, which suggests highly effective “cold-to-hot” TME reprogramming. Our central
hypothesis is that precise coupling of a standard lymph node-directed CD8+ T cell vaccine “prime” with a
tumor-directed immuno-NP “pull” for a novel “prime-pull” approach can provide the key missing link for effective
cancer vaccination. Specific Aim 1 will identify optimal function of an immuno-NP pull in terms of immuno-NP
design and co-treatment with anti-PD1. Specific Aim 2 will develop a precise “prime-pull” coupling schedule.
Specific Aim 3 will evaluate safety and toxicity for effective dose/scheduling “prime-pull” regimens. Dr.
Atukorale's career goals are to establish a nanomaterials-based cancer immuno-engineering laboratory as an
independent investigator. She will develop immuno-nanomaterials tools that drive, quantify, and interrogate
immunity, specifically in the context of lethal cancers. Dr. Atukorale's strong career development plan includes
significant new research collaborations, a senior advisory committee, research presentations, faculty-level
workshops, and plans for subsequent grant proposals. Her future sponsoring institution will be based in both
Schools of Medicine and Engineering, in direct line with her highly interdisciplinary research interests.

Public health relevance
PROJECT NARRATIVE Despite their transformative public health promise, traditional cancer vaccines have had poor clinical responses since vaccine-specific systemic T cells often cannot traffic to immunosuppressed tumors. Our central hypothesis is that precise coupling of a standard lymph node-directed vaccine “prime” with a novel tumor-directed immunostimulatory nanoparticle that reverses local immunosuppression to “pull” or recruit systemic vaccine-specific T cells is the key missing link in effective cancer vaccination. Successful implementation of this proposed “prime-pull” cancer vaccination strategy has the potential for far-reaching public health impact in treatment, particularly of otherwise lethal cancers.